Intracellular pathogens and innate immunity

Portnoy, C/1 Daniel A. 2 P01 AI063302-06 G.) ,-- the project. their commitment to ensure biosafety. The aims represent a reduction in year timeframe. Also note that the Project 5 has been deleted since Russell Vance received R01

Public health relevance
The proposed studies will lead to the characterization of a host system of innate immunity that will lead to vaccines and/or therapeutics to treat disease, with relevance to biodefense, emerging infections and global health.